Neural Mechanisms of Sensory OverResponsivity

Project Summary
Sensory over-responsivity (SOR), the unusual negative response to typically non-noxious stimuli, represents
a prominent feature of many neurodevelopmental conditions, including Autism Spectrum Disorder (ASD),
Anxiety, Attention Deficit/Hyperactivity, and Developmental Coordination Disorders. SOR severely disrupts all
aspects of a child's development, including the ability to learn and socially engage. Despite growing recognition
of SOR as a core feature in neurodevelopmental conditions, the neural mechanisms of SOR remain unclear.
As a result of this gap, SOR has historically been thought to be “behavioral” or due to “bad parenting” or a
consequence of “having autism”. This percept has been challenged by data from our lab and others showing
white matter microstructural and functional imaging differences in children with sensory processing dysfunction
(SPD) and in children with ASD/SOR. Delineating the underlying neural networks that subserve SOR, both
auditory and tactile, will not only guide our understanding of this condition, but also shift the conceptualization
of SOR to that of a treatable neurologic condition. Obtaining the neural signature of SOR will contribute to
finding a biomarker for neural remodeling with cognitive training paradigms similar to what we have piloted in
the domain of cognitive control. Our work utilizing in-lab direct assessment of auditory SOR will test the
scientific premise that SOR results from the disconnection of a higher-order SOR network: the Posterior
Corona Radiata, Superior Longitudinal Fasciculus, and the Cingulate Bundle. We will further determine
whether this putative SOR network reflects a general vulnerability in the posterior periventricular regions, which
are rich in highly connecting white matter tracts, or is specific to auditory SOR. Furthermore, if this
microstructural disconnection is SOR specific, then is it a multi-domain SOR network or does each sensory
domain (e.g. auditory and tactile) rely on a unique set of connections-- as is suggested by the non-overlapping
sensory domain phenotypes in affected children? A multifaceted phenotype and neuroimaging approach is
required to answer these questions. The objective of this proposal is to advance our direct assessment of
sensory related behavior and apply novel structural neuroimaging methods to elucidate the neural architecture
of SOR using an RDoC approach. To achieve this goal, we will assess auditory and tactile SOR using the
Sensory Processing: Three Dimensions Assessment (SP-3D:A) paired with innovative structural imaging,
Neurite Orientation Dispersion and Density Imaging, for detailed microstructural assessment, and Edge
Density Imaging, for advance connectome assessment, in 170 children, ages 8-12 years, with
neurodevelopmental concerns. All phenotype and neuroimaging data will be made available to the field in
order to support ongoing understanding of sensory processing in this unique data set.

Public health relevance
Project Narrative To date, the neural mechanisms of sensory over-responsivity (SOR) remain poorly understood despite extensive neuroimaging research in children with co-morbid categorical conditions such as autism and attention deficit disorder. This work will take a “sensory-first” approach to the assessment of children with neurodevelopmental concerns and lay the ground work for understanding why children experience atypical sensory modulation based on brain connectivity analysis and provide an objective biomarker to be used for future cognitive training interventions.